IAS 2025. the 13th IAS Conference on HIV Science, Kigali, Rwanda, 14-17 July 2025

IAS 2025, the 13th IAS Conference on HIV Science, will be held from 14 to 17 July 2025 in Kigali, Rwanda. With an expected attendance of 6,000 participants, it will provide a powerful platform to catalyse action based on the latest cutting-edge HIV research. The location of IAS 2025 will allow for a much-needed focus on challenges and opportunities in some of the world’s most HIV- affected regions while offering insights gained from many other regions. IAS 2025 will be decisive to advance the research agenda across the full spectrum of relevant fields of inquiry, and forge the all-important collaborations that are required for success.

Public health relevance
There have been remarkable advances in HIV science over the past years, from significant progress in long-acting compounds for both prevention and treatment, through progress in HIV basic science and cure research, to our understanding of social and behavioral factors, and in the growing field of implementation research. However, to address the challenges mapped out in our Specific Aims, concerted global efforts across scientific disciplines remain imperative. IAS 2025 will be a crucial platform to advance the research agenda across the full spectrum of relevant fields of inquiry and forge the all-important collaborations that are required for success. In basic science, IAS 2025 will highlight emerging insights from recent HIV cures, including the second Berlin patient; further insights into HIV reservoirs, and new insights in basic immunology which may have important implications for the next generation of HIV vaccines, including new platforms and approaches for which Rwanda is developing capacity. Advances, and challenges, in clinical science including the expanding role of long-acting and injectable antivirals, treatment choice, emerging data on HIV resistance in Africa and globally, and the many challenges associated with HIV and aging will be major foci. HIV-associated malignancies, including recent increases in the prevalence of HIV-associated Kaposi’s Sarcoma in several African populations will be an important component of the clinical science. The global increase in both bacterial and viral sexually transmitted infections (STIs), and in antimicrobial resistance, will cross-cut both treatment and prevention sciences. In HIV prevention, emphasis will be on long-acting technologies - including Lenacapavir - and on implementation and access for this and other potent long-acting products, as well as on combination prevention. The social and behavioral science track will focus on community-led interventions, which will also be explored to draw lessons learnt and foster community efforts for universal access to HIV care and management. While HIV science is truly in a remarkable period of advancements, the challenges of delivery, access, pricing structures, and supply chain challenges, make implementation increasingly complex. Cross-cutting issues such as mental health, and HIV and substance use, continue to affect low-, middle-, and high-income countries. IAS 2025 will confront these realities with a robust implementation science agenda aimed at maximizing the impact of scientific progress on health and wellbeing. Research conducted on HIV, tuberculosis, and STIs at the global level provides direct benefits for combating these diseases within the United States.